Prenatal Origins of Neurometabolic Consequences

1 ABSTRACT
2
3 There is growing incidence of neurodevelopmental disorders (NDD). Causes for NDDs include ischemic
4 placental disorders (IPD) with fetal/intra-uterine growth restriction (FGR/IUGR), perinatal asphyxia, and
5 hypoglycemia. Exploration of connections between aberrant placental health and NDDs has occurred. Besides
6 the intra-uterine environment (IUE), genetic mutations also contribute to a subset of NDDs, forming an IUE-gene
7 paradigm. We have focused on the neuronal glucose transporter isoform 3 (GLUT3; gene: glut3). Glut3 gene
8 mutations are reported with NDDs/cognitive disabilities. Glut3 mutations with exposure to an adverse IUE may
9 portray expansive effects upon NDD endophenotypes. Development of diagnostics and early dietary
10 interventions is much needed. We have shown that IUGR and hypoxia-ischemia perturb developing brain glut3
11 expression perturbing neurobehavior. We also created murine glut3 deletions, that reduced trans-placental
12 glucose transport leading to postnatal NDD (excitatory autism spectrum disorders), where small extracellular
13 vesicles (sEVs) fueling diagnostics, and ketogenic dietary intervention are being explored. We next disengaged
14 placental glut3 gene from neural-specific glut3 mutations towards deciphering independent neural mechanisms
15 behind NDDs. We also created glut3 expressing human brain organoids from induced pluripotent stem cells
16 (iPSCs). Assessing pre-clinical ketogenic dietary effects targeting NDDs, will yield novel results. To achieve this
17 goal, we will test the hypothesis, that IUE and neural glut3 mutations/dependency cause NDDs by
18 perturbing neurodevelopment with a potential for amelioration. The aims are: 1) a. To investigate changes
19 in cell numbers per cell type and cell-specific transcriptomics in cerebral cortices (CC) with neural progenitor
20 cellular (NPC) absence of glut3 by using nestin-driven conditional null postnatal mice. This will be accomplished
21 by 10X genomics single cell (sc) RNA-sequencing and bioinformatic analyses, followed by in-situ hybridization
22 (ISH)/immunohistochemical (IHC) detection of major changes in key transcribed/translated products in specific
23 cell types. b. To assess administration of prenatal versus postnatal ketogenic diet as an early intervention in
24 ameliorating NDD. 2) a. To explore neural processes and cellular profile in CC with or without MoMCR/IUGR in
25 targeted absence or overexpression (OE) of glut3 in excitatory neurons/NPCs using Emx1-driven conditional
26 null and OE mice during the life course from embryonic and postnatal to the adult. This will entail deconvoluting
27 bulk CC RNA-seq with ISH/IHC, with non-invasive detection of perturbed transcriptome/proteins in circulating
28 sEVs. b. To examine the impact on CSF/plasma metabolomics, neuronal function and neurobehavior in the adult
29 offspring. 3) a. To develop cortical organoids from control iPSCs with glut3 OE and/or glut3 deletions, and
30 examine cellular profiles by deconvoluting organoid RNA-seq with scRNA-seq and ISH/IHC. b. To interrogate
31 the effect of hypoxia and hypoglycemia with/without ketones/lactate on iPSCs, NPCs and cortical organoids.

Public health relevance
PROJECT NARRATIVE Placental disorders that affect the prenatal environment influence early neurodevelopment that underlies many neurodevelopmental disorders with major consequences throughout the life course. We will study neural mechanisms responsible for such cognitive disabilities towards developing diagnostic capabilities and exploring early dietary interventions aimed at reversal of these devastating conditions. These studies subsequently will have a major impact on infant outcomes and adult neurobehavioral functioning in society.